Clinical Resource for Alcoholic Hepatitis Inestigation

Project Summary
Alcoholic hepatitis (AH) is an acute manifestation of alcoholic liver disease (ALD), often with a
grave prognosis. Despite the positive effects of corticosteroid treatment on short-term survival,
this treatment is not ideal and approximately half of patients still die after a short time period. A
major unmet need in the study of acute AH is the lack of a reliable animal model that mimics the
entire spectrum of this disease in humans. Because translational research based on human
samples has a key role in the understanding of mechanisms of alcoholic hepatitis, the collection
of bio specimens from patients with severe AH could help substantially in the design of new
therapeutic strategies. The liver transplant (LT) program for acute AH at Johns Hopkins provided
a unique opportunity for us to create a clinical resource that now serves the alcohol research
community and facilitates access to otherwise unavailable specimens. With support from this
R24 grant, we have created a centralized facility for collecting human samples. The availability of
a large amount of liver tissues and different liver cell types from severe AH patients to the alcohol
research community has generated an innovative resource for translational research of acute AH.
In the last funding period, we have provided our resource to 50 investigators from over 30
institutions/universities resulting in 18 publications in prestigious journals. The goal of this R24
grant renewal is to continue developing clinical resources for severe AH investigations and to
continue meeting investigators’ current and increasing needs and liberally provide our resource
to the entire alcohol research community. Specifically, we need to make more human tissues
(explanted livers from patients with severe AH and other liver diseases) available to any
investigators requesting these. In addition, we will provide expertise at Johns Hopkins to generate
single-cell transcriptome and proteome databases from severe AH that may serve the alcohol
research community and beyond. Specific aims will include maintaining a centralized facility for
collecting human samples from patients with severe AH and other liver diseases and continually
providing our clinical resources to any investigators requesting them, generating single-cell RNA-
sequencing (scRNA-seq) datasets and proteomic and protein post-translational modifications
(PTM) datasets from diseased livers in patients with severe AH or alcoholic cirrhosis (AC) and
making them available to the alcohol research community for data mining/hypothesis generation.
We will continue to promote collaboration through sharing our unique clinical resource.

Public health relevance
Narratives The liver transplant (LT) program for acute alcoholic hepatitis (AH) at Johns Hopkins provided a unique opportunity for us to create a clinical resource that now serves the alcohol research community and facilitates access to otherwise unavailable specimens. We propose to continue meeting investigators’ current and increasing needs and liberally provide our resource to the entire alcohol research community. Hopefully, given the enhanced efficiency of collaboration, a nationwide team can make progress towards better care and therapeutics for this difficult patient population.